The Role of Polycomb Group Proteins in Prostate Cancer

Principal Investigator/Program Director (Last, first, middle): Chinnaiyan, Arul, M. Abstract: Our group has been involved in the molecular profiling of prostate cancer to identify novel clinical biomarkers, candidate regulatory genes, and therapeutic targets. One of the